Oxidation-Specific Epitope IgA in Pulmonary Fibrosis

ABSTRACT
The pathophysiology of idiopathic pulmonary fibrosis (IPF) remains poorly understood, and elucidation
of the molecular mechanisms of IPF pathogenesis is key to the development of new therapeutics. There is
evidence of adaptive immune dysfunction in IPF, as evidenced by aggregates of T and B lymphocytes within IPF
lungs and the development of autoantibodies, particularly IgA. The specific epitopes however are largely
unknown. Therefore, evaluating links between B cells, IgA, and fibrosis in IPF may provide insight into disease
pathogenesis and novel therapeutic opportunities. Oxidation-specific epitopes (OSEs) are found on oxidized
lipids and apoptotic cells. OSEs are generated during lung injury and promote fibrosis. Antibodies to OSEs,
primarily IgM as well as IgG, have been shown to play a role in a variety of inflammatory disease processes.
However, nothing is known about the antibody response to OSEs in humans with IPF or the role it may play in
disease pathogenesis, and these are the subject of this proposal. In supporting preliminary data for this proposal,
we identify novel circulating IgA against OSE (IgAOSE) which are significantly elevated in patients with IPF and
positively correlate with disease severity. Using high-dimensional immunophenotyping by mass cytometry
(CyTOF) we identify a novel B cell subset which correlates with IgAOSE levels. Interestingly, this subset resembles
double negative 2 (DN2) B cells and bears markers indicative of lung homing (CXCR3) and autoreactivity (IL21r).
We also show that the key fibrosis-related cytokine TGFb promotes IgAOSE secretion, providing a mechanistic
link to IPF disease pathogenesis. Additionally, we show that the same IgAOSE is present in mice and increased
in the lung during injury. Our overall hypothesis is that lung injury drives local secretion of IgAOSE through TGFb
and that this propagates fibrosis through a positive feedback cycle. We will test this hypothesis through three
specific aims. In Aim 1, using multiple independent cohorts: the Prospective tReatment EffiCacy in IPF uSIng
genOtype for Nac Selection (PRECISIONS) clinical trial (NCT04300920), the UVA ILD Natural History Cohort,
and two external validation cohorts (University of Chicago, University of Michigan), we will test the hypothesis
that elevated circulating IgAOSE mark a unique molecular endotype in IPF. In Aim 2 we will test the hypothesis
that IgA+ DN2 B cells are spatially related to fibrosis and TGFb in human lungs using our novel Quantitative
Remodeling Scorer (QRS) to resolve fibroproliferative injury at cellular scales. We will also perform BCR
repertoire sequencing of sorted lung B cells. In Aim 3, using gain- and loss-of-function murine models, we will
test mechanistically the connections between lung TGFb, IgAOSE, and fibrosis. The mechanistic insights from
these studies will provide a novel area for potential rapid development of first-in-class therapeutics for IPF and
potentially other fibrotic lung diseases, including new monoclonal antibodies or an anti-fibrosis vaccine.

Public health relevance
PROJECT NARRATIVE Idiopathic pulmonary fibrosis (IPF) is a progressive scarring lung disease with a poor prognosis and limited treatment options. This proposal aims to better understand how the immune system, particularly a specific subset of B cells through production of IgA, can affect lung injury and repair. This knowledge may lead to new treatments for this morbid lung disease.